Latent Profile Analysis in Child Bereavement

PROJECT SUMMARY
Parental death is the most profound childhood experience, with long-term and negative mental health
consequences, including elevated risk for depression and suicide, compared to the general population. Early
adolescents are particularly vulnerable to the resultant consequences of a parental death. This age group is
developing and adjusting to shifts in their cognition, motivation, social behaviors, and environments, each of
which shapes their interactions and relationships. Early stress experiences, such as a parental death, influence
the child’s development by provoking emotional crises. These crises may contribute to the development of
mental health disorders and persist into young adulthood, the peak age for mental illness onset.
To mitigate these effects, bereavement interventions have targeted this population to enhance adaptive coping
and emotional expression. However, empirical studies evaluating the effectiveness of these interventions are
limited in number and methodological rigor, and there is little data regarding their long-term effectiveness.
Moreover, these studies use variable-centered approaches, which assume all grief responses are the same,
rather than person-centered approaches to account for variation in experience and individual characteristics.
This application will address these limitations by leveraging a person-centered analysis (i.e., Latent Profile
Analysis) to examine: individual support-seeking coping and emotional expression characteristics at baseline
(i.e., near time of loss), mental health outcomes across child- and young adulthood based on those individual
characteristics, and if individual differences at baseline predict intervention response. This application aligns
with NICHD and NIMH priorities of enhancing understanding of longitudinal developmental and mental health
outcomes of bereaved children by identifying risk factors, behavioral indicators, and intervention responses.
These aims will be addressed through person-centered analyses that leverage a rich and unique dataset with
five waves of data spanning child- to young adulthood in a sample of 244 parentally-bereaved children. The
specific aims are: (1) to identify subgroups of bereaved children based on patterns of coping and emotional
expression, (2) identify heterogeneity in longitudinal depression and suicide outcomes as a function of child
coping and emotional expression patterns, and (3) examine ways in which intervention effects differ based on
profile membership. Person-centered analyses are necessary for understanding the individual differences that
contribute to heterogeneity in mental health outcomes and intervention response, and considers the dynamic
nature of grief. This research is a timely public health priority, given the stark increase of parental loss due to
COVID-19. The research and training outlined in this NRSA F31 predoctoral fellowship application will equip
me with the skills and support needed to pursue a successful career as an independent research scientist, and
will increase my knowledge of relevant theoretical models and their application to prevention, competencies in
advanced statistical methods for longitudinal research, and scientific writing, and dissemination.

Public health relevance
PROJECT NARRATIVE This application will investigate the ways in which parentally-bereaved children vary based on their individual patterns of coping and emotional expression as well as identify longitudinal differences in mental health outcomes and intervention effects based on those individual patterns. This study will use a rich, unique dataset with five waves of data that span from the childhood parental loss into young adulthood, using a sample from 244 parentally-bereaved children. This study is especially timely given the stark increase of parental loss due to COVID-19, and will provide a rigorous evaluation of the longitudinal effects of childhood parental loss and bereavement intervention efficacy; findings will inform theory, preventive intervention efforts, and promote positive development.